Clinical Prediction of Hepatotoxicity & Comparative Hepatic Safety of Medications

Abstract: Drug-induced hepatotoxicity, defined as liver injury caused by exposure to a medication, is the most frequent reason for withdrawal of marketed medications and one of the most common reasons for termination of otherwise promising therapeutic agents during pre-clinical studies. It is also the leading cause of acute liver failure among patients referredfor liver transplantation in both the U.S. and Europe. The determination of the comparative safety of medications is an area of major importance in Comparative Effectiveness Research. Given the clinical and public health impact of drug-induced hepatotoxicity, the development of methods to predict the likelihood of liver failure in the setting of hepatotoxicity and determination of the comparative risk of liver failure for medications within particular drug classes are crucial to ensuring the comparative safety and effectiveness of medications. To date, no studies have yet yielded a validated method to predict the potential for a medication to lead to liver failure, and no data have compared the risk of liver failure associated with different medications within drug classes. To address these issues, this proposal first seeks to develop and validate a predictive index to classify patients with hepatotoxicity by their risk of progression to liver failure (Aim 1). Using data from Kaiser Permanente Northern California (KPNC), we will start by evaluating the performance of the well known but unproven Hy's Law, and then seek to improve upon it, by modifying cut-off points for liver aminotransferases and total bilirubin, examining their rate of rise, and evaluating whether additional commonly available biomarkers improve predictive ability to identify outcomes of acute liver failure. Once the parameters that best predict liver failure are determined, internal validation will be performed. In the second phase of the study, external validation of the predictive index will be conducted using data from the National Veterans Affairs (VA) Health Information System (Aim 2), which will provide information on its generalizability, particularly in AHRQ priority populations. We will then compare the risk of liver failure associated with different medications used for the treatment of priority conditions of importance to the Medicare and Medicaid programs using data from both KPNC and the VA (Aim 3). We will first examine classes that include a medication with known hepatotoxicity, to confirm our approach, and then compare medications within other important classes. Finally, using the index developed in Aim 1, we will determine the risk of severe hepatotoxicity for medications in the drug classes evaluated in Aim 3, to provide further evidence on the comparative hepatic safety of these medications (Aim 4). Thus, the overall goal of this series of studies is to produce new methods and valuable data that will enhance substantially the comparative safety and effectiveness of drug therapies for a variety of priority clinical conditions, with a particular focus on their comparative hepatic safety.

Public health relevance
Public Health Relevance: Given the clinical and public health significance of drug-related hepatotoxicity, the development of a validated index to identify accurately signals that predict the potential for severe hepatic injury would enable differentiation of drug therapies with little likelihood for severe liver injury from those with increased potential for liver failure. Comparing within drug class the association between the use of different medications and liver failure is necessary to provide evidence on the comparative hepatic safety of these medications, informing decision-making about the appropriate treatments for various conditions and settings. __SpecificAimsTextDelimiter__ RESEARCH PLAN: "Clinical Prediction of Hepatotoxicity & Comparative Hepatic Safety of Medications" A. STATEMENT OF HYPOTHESES AND SPECIFIC AIMS Drug-induced hepatotoxicity, defined as liver injury caused by exposure to a medication 1,2, is currently the most frequent reason for withdrawal of marketed medications after release and one of the most common reasons for termination of otherwise promising therapeutic agents during pre-clinical studies 3,4. From a clinical standpoint, a missed diagnosis of severe drug-induced hepatotoxicity can lead to morbidity and mortality from liver failure 5, and it is now the leading cause of acute liver failure among patients referredfor liver transplantation 6-8. The determination of the comparative safety and effectiveness of medications is an area of major importance in Comparative Effectiveness Research 9. Given the clinical and public health impact of drug-induced hepatotoxicity, the development of new methods to predict the likelihood of liver failure in the setting of hepatotoxicity and determination of the comparative risk of liver failure for medications within drug classes would be novel and are crucial to understanding the comparative safety of medications 10,11. Currently, the most commonly employed method to predict the potential for a medication to lead to liver failure is "Hy's Law" 12-17, created out of clinical impressions by Dr. Hyman Zimmerman at the Armed Forces Institute of Pathology. Hy's Law, which uses elevations in both liver aminotransferases and total bilirubin for clinical prediction, has been invoked by the U.S. Food and Drug Administration (FDA) and pharmaceutical manufacturers as a key predictor of liver failure 18,19. Despite its extensive use, no studies have validated or sought to improve Hy's Law to classify cases of drug-induced hepatotoxicity by risk of progression to liver failure, despite the enormous impact of this adverse event. Further, almost no data have compared medications within drug classes for their risk of serious hepatotoxicity and liver failure. The results of such studies would enhance substantially the comparative safety of medications used for the treatment of any given condition. This research proposal first seeks to develop and validate a clinical predictive index to classify patients with hepatotoxicity by their risk of progression to liver failure. We will seek to maximize the ability of Hy's Law to identify outcomes of liver failure by modifying cut-off points for liver aminotransferases and total bilirubin, examining their rate of rise, and evaluating whether additional commonly available biomarkers improve predictive ability. Once the parameters that best predict liver failure are determined, internal and external validation will be performed in two separate populations using observational data from routine practice. A validated method for accurately identifying signals that predict the potential for severe hepatic injury could be used more confidently by the FDA and pharmaceutical manufacturers to discontinue development and prevent approval of potentially hepatotoxic drugs as early as possible, avoiding unnecessary exposure to these medications. This index could potentially change current practice by enabling differentiation of drug therapies with little likelihood for severe liver injury from those with increased potential for liver failure. This would have a major public health benefit by reducing greatly morbidity from medications and enhancing drug safety. This proposal will then apply these methodologic developments to compare the risk of severe hepatotoxicity associated with different medications used for the treatment of priority conditions of importance to the Medicare and Medicaid programs. Finally, we will compare the risk of liver failure associated with medications within these drug classes to provide additional evidence on the comparative hepatic safety of these medications, informing decision-making about the appropriate treatments for various clinical conditions and settings. Thus, these study aims will ultimately produce new methods and valuable data that will enhance substantially the comparative safety and effectiveness of drug therapies for a variety of important clinical conditions. Specific Aim 1: To derive and internally validate a predictive index, modified from Hy's Law, to classify cases of hepatotoxicity by risk of progression to liver failure. We will accomplish this aim using data from Kaiser Permanente Northern California (KPNC) 20. Our hypothesis is that a predictive index can be developed that will have a lower bound of the 95% confidence interval (CI) of the positive and negative predictive value estimates of at least 80%, since we feel that these represent clinically relevant predictive values to enable classification of patients with hepatotoxicity into low- and high-risk categories of liver failure. We will identify the combination of relevant laboratory variables (i.e., liver aminotransferases, total bilirubin, alkaline phosphatase, and international normalized ratio [INR]) and their cut-off points that best predict liver failure. The main outcome will be acute liver failure, which will initially be identified by physician-assigned diagnostic codes suggestive of this outcome and then confirmed by medical record review 6,21,22. As part of this aim, we will characterize liver failure cases by apparent mechanism of hepatotoxicity, based on their clinical presentation. Specific Aim 2: To externally validate the predictive index developed in Aim 1. External validation will be performed using data from the National Veterans Affairs (VA) Health Information System 23. The main outcome will again be acute liver failure, identified initially by diagnostic codes and confirmed by chart review. We hypothesize that the index in Aim 1 will appropriately classify patients by their risk of developing liver failure. The prior two study aims focus exclusively on the derivation and validation of a predictive index to classify patients with hepatotoxicity by their risk of progression to liver failure. However, the risk of severe hepatotoxicity and liver failure associated with existing medications in commonly used drug classes also needs to be evaluated, particularly medications with known hepatotoxicity and those prescribed to treat common medical conditions. This is therefore the focus of the next two Specific Aims. Specific Aim 3: To examine the comparative risk of liver failure associated with medications within drug classes that are prescribed for the treatment of conditions of importance to the Medicare and Medicaid programs. We will accomplish this aim using the cases and controls selected in Aims 1 and 2. Sub-Aim 3a: To determine the comparative risk of liver failure for medications in drug classes with a known hepatotoxic medication (to confirm our approach). Drug classes to be evaluated in this aim have at least one member medication known to be strongly associated with hepatotoxicity compared to others in the class. These classes will include: anti-tuberculosis agents (i.e., isoniazid, rifampin, ethambutol, pyrazinamide), thiazolidenediones (i.e., troglitazone, rosiglitazone, pioglitazone), and selected non-steroidal anti- inflammatory agents (specifically, bromfenac, ketorolac, and diclofenac). We hypothesize that isoniazid, troglitazone, and bromfenac will be most strongly associated with liver failure, respectively. Sub-Aim 3b: To determine the comparative risk of liver failure for medications without known hepatotoxicity prescribed for the treatment of priority conditions in the Medicare and Medicaid programs. We will determine the association between liver failure and medications within the following drug classes: statins; proton pump inhibitors; antiretrovirals for HIV/AIDS therapy; anti-depressants; and anti-psychotics. Specific Aim 4: To examine the comparative risk of severe hepatotoxicity associated with medications within drug classes that are prescribed for the treatment of conditions of importance to the Medicare and Medicaid programs. Using data from both KPNC and the National VA Health Information System, we will apply the predictive index developed and validated in Aims 1 and 2 to examine the comparative risk of severe hepatotoxicity for medications within the drug classes of interest noted in Specific Aim 3 Sub-Aim 4a: To determine the comparative risk of severe hepatotoxicity for medications in drug classes with a known hepatotoxic medication. Sub-Aim 4b: To determine the comparative risk of severe hepatotoxicity for medications without known hepatotoxicity prescribed for the treatment of priority conditions for the Medicare and Medicaid programs.